Transition-State Inhibitors of Fatty Acid Synthase

[unreadable] DESCRIPTION (provided by applicant): Project Summary/Abstract: Type 2 diabetes (T2D) and obesity are major health concerns that have been increasing at an alarming rate over the last few decades resulting in costs to the medical system upwards of $100 billion annually in related medical expenses. Fatty acid synthase (FAS-1) is a key enzyme in mammals which regulates the de novo synthesis of saturated fatty acids such as palmitate and stearate. FAS plays an important role in energy homeostasis by converting excess caloric intake into lipids for storage and providing energy when needed via beta-oxidation. Elevation of plasma free fatty acid levels is an important clinical feature in T2D and obesity. Central inhibition of FAS-1 by the inhibitors cerulinin and C75 have been shown to suppress food intake, lead to dramatic weight loss and improved insulin responsiveness in mice. This Phase I SBIR grant proposes to exploit the recent findings that the FAS-1 beta-ketoacyl synthase (KS) and the thioesterase (TE) domains contain an active site triad which acts analogous to proteases in their mechanism of substrate cleavage. Using structure-based drug design and computational chemistry, we propose to design and synthesize focused transition-state inhibitory libraries against the TE and KS domains of human fatty acid synthase (FAS-1). The Specific Aims of this Phase I SBIR grant are: (1) using the recently published x-ray crystal structure of the TE domain of human FAS-1 to design and synthesize potent and specific transition-state compound inhibitory libraries with desirable drug-like properties, (2) to design and synthesize focused transition-state inhibitory libraries directed to the KS domain of human FAS-1 using an in-house generated high quality 3D homology model of the KS domain of human FAS-1, and (3) to test in enzyme and cellular assays these focused transition-state compound libraries to select potent inhibitors of FAS-1. Once enzyme inhibitors are identified, these hits will be screened in cell culture for their ability to inhibit cellular fatty acid synthesis and tested for selectivity and toxicity. The ultimate goal of this phase I grant is to advance a FAS-1 transition-state inhibitor to the lead optimization phase where upon Phase II funding we would: (a) clone and express human TE, (b) conduct co-crystallization studies on inhibitor/protein complexes, (c) model active inhibitors, (d) rationally design and synthesize potent and selective in vivo active FAS inhibitors, and (e) advance a clinical candidate based on positive results in in vivo efficacy models. Project Narrative: Type 2 diabetes (T2D) and obesity are major health concerns that have been increasing at an alarming rate over the last few decades resulting in costs to the medical system upwards of $100 billion dollars annually in related medical expenses. 1 major factor contributing to this increase in incidence of T2D is an increase in obesity, which is the single most significant contributor to the pathogenesis of diabetes. This proposed project has the potential of alleviating obesity, the effects of which on public health reach far beyond diabetes and its associated diseases (cardiovascular disease, retinopathy, neuropathy, nephropathy), obesity has been associated with stroke, hypertension, heart disease, gallbladder disease, sleep apnea and other breathing problems, gout, certain [unreadable] types of cancers, osleoarthritis, and depression. [unreadable] [unreadable]